Hematopoietic Stem/Progenitor Cell-Based Chimeric Antigen Receptor Gene Therapy for HIV Infection

Project Summary
More than 4 decades into the pandemic, HIV disease remains a considerable public health concern without a
practicable cure. Drug-based therapy can control HIV but is costly, has severe side effects, and is not curative.
Stem-cell based therapies have provided the only known cures for HIV infection, with three individuals
functionally cured to date. However, replicating these successes has been challenging due to the high
toxicities of treatment, need for transplant antigen matching, and requiring extensive myeloablation. However,
these “cures” strongly suggest that immune system modification involving hematopoietic stem/progenitor cell
(HSPC) transplantation can play a strong role allowing HIV clearance from the body. Gene therapeutic
modification of autologous HSPCs to allow resistance of engrafted cells to infection along with the production
of cells that are capable of targeting and eliminating HIV infected cells represents a more targeted approach to
a HIV cure for all. Through systematic development, we have established an approach to direct cells to target
HIV infection in vivo using a novel and optimized HIV-specific chimeric antigen receptor (CAR). This optimized
HIV-specific CAR contains a truncated version of the HIV-binding region on the CD4 molecule (the D1D2
regions) with the CD3 zeta TCR signaling domain along with a 4-1BB costimulatory molecule signaling domain
(termed D1D2CAR41BB). Extensive preclinical studies in humanized mice have determined that the
D1D2CAR was superior in comparison to other CAR candidates in allowing the modification of HSPCs,
producing lifelong safe engraftment, enabling development into mature CAR-expressing cells, and resulting in
antiviral suppression of HIV. With this strong preclinical data suggesting the safety and feasibility of this
approach, we seek to work towards investigational new drug (IND) development and clinical implementation of
this approach. In this proposal, we plan to 1) Develop a comprehensive product development strategy for IND
submission, 2) Formulate a strategic plan for clinical development, and 3) Establish a comprehensive plan for a
regulatory strategy. By address these aims, we seek to develop a comprehensive IND-directed product
development strategy to facilitate phase I clinical trials with this approach to attempt to functionally cure HIV
infection.

Public health relevance
Project Narrative We have previously developed a blood forming stem cell-based gene therapy to treat HIV infection that shows promise in the treatment of people living with HIV (PLWH). In this proposal, we plan to develop detailed product development, clinical, and regulatory strategies to enable us to conduct INTERACT and pre-IND discussions with the FDA in anticipation of preparing the necessary documentation for Phase I clinical trials and IND development of this strategy. Ultimately, we aim to develop this approach for first-in-human clinical trials to attempt to cure HIV infection.